Project START: Screening to Augment Referral to Treatment

DESCRIPTION (provided by applicant): Substance abuse is associated with high costs to individuals and to society but less than one- third of individuals who are drug dependent and 6% of those who abuse drugs ever receives treatment. Screening, a brief intervention and referral for treatment (SBIRT) for substance abuse and deployed in a primary care setting has therapeutic potential but clinicians typically have less than 10 minutes with a patient and must address a range of medical problems. SBIRT, delivered by computer or nurse, would be a strong addition to a primary care clinician's therapeutic armamentarium for substance abusers but these interventions need to be tested against usual care. Women, who have lower rates of substance abuse treatment, typically receive primary medical care in a reproductive health setting. The American College of Obstetricians and Gynecologists recommends universal screening to determine if women abuse substances but, other than for alcohol and tobacco, there are no empirical data to support the effectiveness of this approach. In fact, the astonishing lack of data on SBIRT in primary care setting is noted by the US Preventative Services Task Force, in a 2008 report. We propose a controlled, pragmatic, randomized clinical trial that would compare two SBIRTs, offered either by computer or a trained nurse, to usual care (a control condition). We will recruit 660 women with a range of psychoactive substance use (e.g. tobacco, marijuana, cocaine, methamphetamines, alcohol, opiates, prescription drugs) and randomize them to a nurse- administered referral based upon motivation principles, a computer referral based upon motivation principles or brief advice. All subjects will receive a pamphlet with information and resources. Random effects and logistic regression models will be used to estimate group differences in primary drug used, treatment initiation, and treatment attendance among the 3 groups at 1, 3, and 6 months. Random effects models will also be used to test the incremental costs of the computer and nurse administered referrals.

Public health relevance
PUBLIC HEALTH RELEVANCE: Screening, brief interventions and referral to treatment for substance abuse have therapeutic potential but are understudied in primary care settings, in women and drug users. We propose a pragmatic trial that would randomize 660 women in a reproductive health setting who have a range of psychoactive substance use (e.g. tobacco, marijuana, cocaine, etc.) problems to a nurse-administered referral based upon motivation principles, or a computer referral based upon motivation principles or brief advice (control condition). Costs of the conditions would be estimated to provide models of cost effectiveness. Project START Narrative Screening, brief interventions and referral to treatment for substance abuse have therapeutic potential but are understudied in primary care settings, in women and drug users. We propose a pragmatic trial that would randomize 660 women in a reproductive health setting who have a range of psychoactive substance use (e.g. tobacco, marijuana, cocaine, etc.) problems to a nurse-administered referral based upon motivation principles, or a computer referral based upon motivation principles or brief advice (control condition). Costs of the conditions would be estimated to provide models of cost effectiveness. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS Substance abuse* is associated with high costs to both individuals and society. Unfortunately, less than one- third of individuals who are drug dependent and 6% of those who abuse drugs ever receive treatment.20 Such discouraging statistics illustrate the need for new strategies to identify and provide treatment interventions for patients with substance use disorders. General medical settings have the advantage of reaching large numbers of patients and in these settings, standardized screening, brief interventions, and referral to treatment (SBIRT) approaches have led to modest reductions in alcohol21 and tobacco use.22 However, it is not clear whether SBIRT 1) leads to reductions in other drugs of abuse and 2) almost no research has investigated whether SBIRT increases attendance to specialty substance abuse treatment. Experts believe that the situation regarding treatment is worse for women than for men.23,24 The preferred and predominant primary care setting among women is a reproductive health setting. In the spirit of a primary care approach, the American College of Obstetricians and Gynecologists recommends SBIRT to determine if women abuse substances and help them reduce or stop their use.25 However, there have been no studies to date that examine the effectiveness of SBIRT for substances (other than alcohol or tobacco) in a reproductive health setting. Moreover, it not clear how these interventions should be delivered (nurse-led vs. computer- assisted) to make them most acceptable to patients and feasible to deliver. Health screening and promotion are hallmarks of nursing care and fully consistent with SBIRT. 26 However, nurses often have limited time in which to address the range of medical, gynecological and obstetrical patient care issues and must be trained to deliver SBIRT. Advances in technology and the increased acceptance of computerized interventions constitute a possible solution to these barriers. SBIRT, delivered either by nurse or computer, would be a strong addition to a primary care clinician's therapeutic armamentarium for substance abusers, but the utility, efficacy, and cost effectiveness of these alternative approaches need to be tested against usual care. We propose to use obstetric-gynecological clinics to conduct a randomized clinical trial that would compare two SBIRTS, delivered either by a trained nurse or by computer, to usual care (a control condition). As part of this trial, we will include outcomes that allow us to assess the cost effectiveness of these three conditions. This application responds to PA -08-263, "Health Services Research on the Prevention and Treatment of Drug and Alcohol Abuse" and PA-07-329, Women and Sex/Gender Differences in Drug and Alcohol Abuse/Dependence. Our Primary Aims are: Aim 1: To assess whether SBIRT, based upon motivational interviewing and delivered either by computer or a trained nurse, leads to decreased use of a subject's primary drug of abuse. Hypothesis #1a: Referrals based upon motivational principles and delivered by computer, as compared to usual care (health brochure with treatment resources), will lead to greater reductions in a woman's primary substance of abuse. Hypothesis #1b: Referrals based upon motivational principles and delivered by nurse, as compared to usual care (health brochure with treatment resources), will lead to greater reductions in a woman's primary substance of abuse. Aim 2: To determine whether SBIRT based upon motivational interviewing and delivered either by computer or by a nurse will promote substance abuse treatment utilization for the primary drug of abuse. Hypothesis #2a: Treatment utilization (eg. treatment initiation, attendance, use of quit-line or medication) will be higher if a woman receives the computer delivered brief intervention than if she receives usual care only. * In this application we use the term "substance abuse" to refer to abuse and dependence of licit and illicit substances as well as prescription drugs used in a non-medicinal manner. If we specifically indicate a particular drug or alcohol or Illness ("abuse" or "dependence"), then the information refers to that subgroup rather than the larger group of individuals with substance abuse and dependence. Hypothesis #2b: Treatment utilization (eg. treatment initiation, attendance, use of quit-line or medication) will be higher if a woman receives the nurse delivered brief intervention than if she receives usual care only. Secondary Aim 3: To compare the relative cost-effectiveness of the three interventions. Hypothesis #3a: Screening and usual care will be the most cost-effective intervention method when the value of an additional unit of effect for the given individual's outcome is relatively low. Hypotheses #3b: Screening, and a brief intervention delivered by computer, will be the most cost- effective treatment method when the value of an additional unit of effect is relatively high. Hypotheses #3c: Screening, and a brief intervention delivered by a nurse, will be less cost-effective than a brief intervention delivered by computer.